Vanderbilt Institute for Clinical and Translational Research (VICTR)

The Vanderbilt Institute for Clinical and Translational Research (VICTR) is a highly functional and integrated clinical and translational (C&T) research infrastructure that has raised the quality and scientific rigor of the research conducted at Vanderbilt and longstanding partner Meharry Medical College. VICTR will contribute to the mission of the CTSA program while leveraging unique resources and expertise within VICTR’s Hub with these new aims: 1) Leverage VICTR's strong collaborative energy to enhance team science methodologies, integrate community engagement principles for all stages of research, and implement programs designed to support studies conducted representative of the population with the disease or condition and that are focused on health needs for all affected populations; 2) Develop and share multi-dimensional data organization methods and informatics tools to promulgate innovation, efficiency, quality, and promote studies that are focused on the health needs for all affected populations; 3) Ensure the translational science workforce is multi-disciplinary and has the skills, knowledge, and resources necessary to advance translation of discoveries; 4) Support the efficiency, quality, and impact of local studies and ‘raise the bar’ for acceptable scientific standards in research conduct; 5) Support the efficiency, quality, and impact of multi-site clinical trials by building and disseminating streamlining programs and promoting novel trial designs; and 6) Utilize unique institutional capabilities to enable the conduct of pragmatic trials during healthcare operations and repurpose existing drugs for new indications.

Public health relevance
The Vanderbilt Institute for Clinical and Translational Research (VICTR) is a highly functional and integrated clinical and translational (C&T) research infrastructure that has raised the quality and rigor of the research conducted at Vanderbilt and partner Meharry Medical College. VICTR will contribute to the mission of the CTSA program, leveraging unique resources and expertise, while elevating and advancing C&T research. Figure 1. Genesis of our CTSA infrastructure and program support over the first 3 CTSA cycles with planned expansion in cycle 4.